Building Research across Interdisciplinary Gaps (BRIDG) R90 Training Program - Administrative Supplement

The T90/R90 Building Research across Inter-Disciplinary Gaps (BRIDG) Complementary and Integrative
Health (CIH) Postdoctoral Clinical Research Training Program is a partnership between the
University of Washington (UW) in Seattle, WA, and the National University of Natural Medicine
(NUNM) in Portland, OR. The overarching objective of the T90/R90 BRIDG program is to prepare the
next generation of clinical investigators to design and carry out competitive, rigorous CIH
programs of research that are innovative, collaborative, and multi-disciplinary, thereby generating
new knowledge and contributing to improving health care. The T90 component of the BRIDG program
provides competitive CIH-trained, doctoral-level clinicians with didactic courses in
clinical research methodology, specific learning modules dedicated to CIH-specific research
topics, and hands-on, clinical research experiences mentored by funded investigators from the
UW. T90s will be graduates or recent graduates of CIH-training institutions. The R90 component
of the BRIDG program provides competitive conventionally trained researchers with training
and mentorship in the practices of integrative health disciplines, including naturopathy,
classical Chinese medicine herbal medicine, and mind and body therapies amongst others. R90s will
be early-investigator level PhDs interested in clinical CIH research. R90s participate in clinical
clerkships, receive research mentorship from funded investigators, and have the opportunity
to collect preliminary data toward grant applications. R90s and T90s train together during weekly
BRIDG Seminars, tri-annual in-person BRIDG Retreats, and annual immersive Methods Workshops to
foster collaboration and learn applications of research methods to CIH research. In total, 6
R90 participants and 6 T90 trainees will be appointed for a maximum of 3 years each over
the course of Years 06-10 of BRIDG. The Specific Aims of the BRIDG program are to: 1. Provide
promising CIH-trained clinicians with clinical research training at the research-intensive UW,
including hands-on research experience, mentorship and didactic training in clinical research
methodologies; 2. Provide promising conventionally trained researchers interested in
collaborative CIH clinical research with experience in CIH clinical practices and
research training at the CIH-intensive NUNM, including clinical observations, research
mentorship and didactic training in complementary health disciplines; 3. Apply innovative online
and distance education approaches to deliver, preserve and disseminate the BRIDG program training
materials; and 4. Evaluate the BRIDG program on a variety of metrics of success in order to
continually improve the program. The products of the BRIDG program include the continued
development of a cadre of cross-trained clinical researchers prepared to design and carry out
competitive rigorous CIH research and contribute significant knowledge to the field; a
collaborative distance learning-oriented training model for CIH clinical research
education; and a digital archive of the BRIDG didactic material that can be made accessible and
disseminated to other interested parties.

Public health relevance
With the increasing public use of complementary and integrative health (CIH) modalities and disciplines, rigorous research is essential so that CIH therapies can be accurately evaluated, and members of the public adequately informed. To help meet the need to rigorously evaluate promising CIH treatments for treating disease and improving health, CIH clinicians need training in clinical and translational research methods, and conventionally trained researchers need grounding in CIH therapies and philosophies. The T90/R90 BRIDG program partnership between the University of Washington and the National University of Natural Medicine is preparing the next generation of clinical investigators to design and carry out competitive, rigorous programs of CIH research that are innovative, collaborative, and multi-disciplinary, thereby generating new knowledge and contributing to improving health care.